Protective monocytes in cerebral ischemic tolerance

Project Summary/Abstract Stroke is a prevalent and devastating disease with limited therapeutic options. Inflammation and immune cells are major components in the pathophysiology of ischemic stroke and contribute to acute and delayed tissue injury. However, our incomplete understanding of the factors regulating the immune responses triggered by cerebral ischemia remains a significant obstacle to the development of effective therapeutic interventions based on modulating post-ischemic inflammation. Besides activation of brain resident immune cells, ischemic stroke is characterized by the recruitment of peripheral innate and adaptive immune cells that participate in the inflammatory response and contribute to the damage. Monocyte-derived macrophages (MMØ) are a major component of the cellular innate immune response to ischemic stroke. MMØ infiltrate the ischemic lesion and perilesional territories early after ischemia and reside in the injured territory for prolonged periods of time. These observations raise the possibility that MMØ contribute to the entire inflammatory process from initiation to resolution with the potential of modulating the outcome of cerebral ischemic injury. The long-term goal of this research program is to elucidate the role of MMØ in stroke pathophysiology and develop the experimental framework for new preventative and therapeutic approaches for ischemic stroke. In the present application, we will test the hypothesis that MMØ are present in the ischemic territory as functionally divergent and molecularly definable populations and that tissue hypoxia is an important determinator for MMØ differentiation and revelation of their neuroprotective capacity. This hypothesis, supported by relevant preliminary results, will be tested by determining: (a) the transition of MMØ from monocytes to long-term resident immune cells in the post-ischemic brain (Aim 1), (b) the effects of the hypoxic environment on tissue distribution and polarization of MMØ (Aim 2), and (c) the role of hypoxia-inducible factor 1? (HIF1?) and glycolytic metabolism in the functional polarization of brain-infiltrating MMØ and their effects on stroke outcome (Aim 3). These goals will be achieved using a mouse model of transient focal cerebral ischemia with assessment of histological and neurological outcome together with a novel model for classifying brain MMØ. This proposal may open the way to new avenues for stroke prevention and therapy based on modulation of MMØ and their precursor, the peripheral blood monocyte.

Public health relevance
Stroke caused by insufficient blood flow to the brain (ischemic stroke) is a leading cause of brain damage, long-term disability and death, but there is a paucity of therapies to protect the brain from its devastating effects. We will examine how certain immune cells, monocyte-derived macrophages, can make the brain more resistant to the lack of blood that causes the stroke. The findings offer the prospect of targeting these cells as a novel treatment for acute ischemic stroke.